Origins of neonatal lung myofibroblasts

PROJECT SUMMARY
The lung mesenchyme consists of heterogeneous cell types that are critical for lung development, architecture,
and maintaining homeostasis in the mature organ. Alveoli mature during the final days of gestation and early
postnatal life through a process called alveologenesis, which involves secondary septation—morphological
changes in alveoli that create additional septa and increase the surface area for gas exchange. Postnatally,
myofibroblasts rapidly expand and contract the lung tissue, facilitating secondary septation. However, the
mechanisms regulating myofibroblast development, expansion, and transient existence remain poorly
understood. In this proposal, we will leverage a novel murine model targeting neonatal alveolar myofibroblasts
to test the hypothesis that these cells are specified by a morphogen gradient of bone morphogenetic protein
(BMP) signaling in the embryonic lung. This signaling drives their clonal expansion in the postnatal lung, followed
by the activation of intrinsic apoptotic pathways that lead to their decline after alveologenesis. Our specific aims
for this proposal are (1) to utilize a novel lineage reporter mouse for alveolar myofibroblasts to study their
expansion and activation of apoptotic pathways; (2) to investigate how the divergence of airway and alveolar
myofibroblasts occurs around the embryonic endoderm in a BMP-dependent manner; and (3) to determine the
necessity and sufficiency of alveolar myofibroblasts in driving secondary septation following neonatal lung injury.
These studies will provide new insights into myofibroblast plasticity, molecular drivers of myofibroblast dynamics,
and identify pathways that could enhance alveolar septation.

Public health relevance
PROJECT NARRATIVE The lung mesenchyme plays a crucial role in lung development, alveolar maturation, and tissue regeneration. We have developed a novel mouse line to target a unique myofibroblast that is embryonically programmed to undergo rapid proliferation and expand in the alveolar region of the neonatal lung. The proposed studies will focus on how the progenitors of these cells are selected and how critical they are for postnatal alveolar maturation.